Collaborative Care to Improve Resilience and Quality of Life among Youth with Non-malignant Blood Disorders

Project Abstract
Adolescents and Young Adults (AYAs) with blood disorders are at high risk of poor physical, emotional,
and social quality of life. On average, they suffer from seven unique, chronic, distressing symptoms. Over 60%
report insufficiently treated pain. AYAs with Sickle Cell Disease (SCD) are at particularly high-risk; their pain,
anxiety, depression, and impaired social and cognitive function persist into adulthood. My central hypothesis is
that AYAs with serious illness experience poor outcomes in part because the stressors of illness compound the
stressors of development. The goal of my research program is to develop interventions to help AYAs navigate
those stressors, in turn alleviating suffering and improving quality of life. To date, I have focused on the population
of AYAs with cancer and been largely successful; I am currently the PI of 4 NCI R01-funded clinical trials testing
the efficacy of a novel resilience coaching program for high-risk teens with cancer or their families.
I am also committed to mentoring the next generation of scientists focused on improving the outcomes
of youth with serious illness. I have been the primary research mentor for 21 trainees and early career faculty;
all 21 remain involved in patient-oriented research at academic institutions. It is critically important to me to
bolster the diversity of the research (and future mentor) workforce; for this reason, 100% of my mentees identify
as women and/or under-represented in medicine (URiM). As a testament to this commitment and my skills, I
received the “Excellence in Mentoring Women” award from the University of Washington in 2021.
Here, I address 2 critical barriers to my continued success: First, few evidence-based psychosocial
interventions are ever integrated in routine clinical care. I want to collaborate with clinicians and communities to
implement my interventions. Second, Social Determinants of Health (SDOH) impact intervention-efficacy. I want to
robustly collect SDOH and better address their impact on intervention efficacy. I will address these barriers via 3
specific learning objectives: (1) Enhance my skills in collecting and investigating SDOH; (2) Develop
knowledge in Dissemination and Implementation Science, with a focus on community-based adaptation and
engagement; and (3) Develop skills in using the Electronic Health Record (EHR) to assess SDOH and patient-
centered outcomes; and 3 specific research aims: (1) Determine the feasibility and acceptability of a novel,
community-based Collaborative Care Model to deliver the Promoting Resilience in Stress Management (PRISM)
intervention among N=25 AYAs with sickle cell disease; (2) Leverage the electronic health record to characterize
relationships between SDOH and outcomes among youth with non-malignant blood disorders; and (3) Examine
relationships between SDOH and intervention efficacy using existing data from my R01-funded trials. These
career development and research activities are significant because they will provide me and my mentees
opportunities and skills to maximize the reach and impact of our interventions, in turn improving the physical,
emotional, and social quality of life of patients and communities in need.

Public health relevance
Project Narrative In this K24 application, candidate Abby R. Rosenberg, MD, MS, MA proposes to expand her research and mentoring skills to optimize the impact and delivery of promising psychosocial interventions among youth with non-malignant blood disorders. Her research aims are to (1) test the feasibility and acceptability of a community- based, collaborative care model to deliver a positive psychology intervention among teens and young adults with Sickle Cell Disease; (2) leverage the electronic health record to evaluate relationships between social determinants of health and outcomes among children with non-malignant blood disorders; and (3) explore the impact of social determinants of health on psychosocial intervention efficacy using existing data from her R01- funded clinical trials. Her career development goals are to: (1) enhance her skills in collecting and investigating social determinants of health; (2) develop knowledge in dissemination and implementation science, with a focus on community-based adaptation and engagement; and (3) develop skills in using the electronic health record to assess patient-centered outcomes.